2024 In Vivo Ultrasound Imaging Gordon Research Conference and Seminar

Project Summary
Ultrasound is a ubiquitous clinical imaging modality supported by a dynamic and scholarly research community.
Until the inaugural Gordon Research Conference (GRC), no conference or professional meeting was explicitly
dedicated to basic science ultrasound research with the goal of improving diagnostic ultrasound. The first GRC
on in vivo ultrasound imaging found an exceptional reception and outstanding feedback. Discussion among the
2022 participants quickly demonstrated the strong need to propose a Gordon Research Seminar (GRS). GRC
and GRS will provide an intimate forum for scientific exchange among scientists and researchers whose primary
area of research is the development of novel biomedical ultrasound techniques and approaches. The proposed
inaugural GRS will feature 3 sessions with dedicated discussion leaders and 11 student speakers selected from
abstract submissions. A 4-member panel discussion on mentorship will conclude the GRS and create a transition
to the GRC for 5 days of fostering discourse and mentoring between trainees and researchers/educators.
Steep increases in real-time computing capabilities, out-of-the-box approaches, and progressive technology
integration have led to dramatic advances in ultrasound imaging and therapy. We are observing the advent of
neuromodulation, wearable ultrasound devices, immunotherapy, super-resolution imaging, and the previously
unthinkable lung ultrasound. In total, they are indicative of a vibrant and active research community. Therefore,
it is vital that this community is provided with an avenue that allows deeper discussion about the future and
direction of in vivo ultrasound and provides engagement of researchers spanning from senior to new and young
investigators. This second biennial Gordon Research Conference (GRC) and inaugural Gordon Research
Seminar (GRS) on In Vivo Ultrasound Imaging aims to provide this avenue for engaging the basic science
ultrasound research community. Ultimately, the success of this conference will result in a recurring
meeting/seminar series to bring research professionals in the area of ultrasound imaging together to address
the latest trends and needs in diagnostic ultrasound. The main goals of the GRC/GRS are: (1) to provide an
avenue to discuss the latest ground-breaking and critical-need technologies in biomedical ultrasound; (2) to
stimulate cross-pollination and validation of different approaches for ultrasound imaging, i.e., to become a
thinktank within the ultrasound imaging community; (3) to identify the needs for the continuing development of
novel ultrasound imaging technologies and where new methods and approaches can be implemented; and (4)
to promote the work of new and young investigators. The GRC and GRS scientific topics focus on ultrasonic
imaging and highlight the latest advancements in diagnostic ultrasound, including ultrasound applications in
therapy.

Public health relevance
Project Narrative Ultrasound imaging, also known as ultrasonography, is the most widespread and accepted clinical imaging modality and offers diagnostic information throughout the human lifespan, starting prebirth. While its dynamic and scholarly research community continually improves image quality, it also develops new ways to benefit from this exciting modality that involves in-vivo biomedical ultrasound applications. This meeting will bring together scientists and trainees from a wide range of backgrounds to discuss and further ultrasonography so that those in need can benefit from lung ultrasound, virtual biopsies, immunotherapy and more, and will soon be seeing wearable ultrasound to understand better how daily activities, ailments, and disorders impact our bodies.